Mechanisms underlying delayed neurocognitive dysfunction in long-covid

PROJECT SUMMARY/ABSTRACT
Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) infection, which causes Coronavirus Disease
2019 (COVID-19), has become a global health crisis. To date, more than 6.5 million deaths from COVID-19 have
been reported worldwide. Amongst survivors, neurocognitive dysfunction and neuropsychiatric disorders, such
as anxiety and depression, are increasingly recognized and can persist for months, or even years. This enduring
neurocognitive and neuropsychiatric distress obligates us to address critical questions about their duration, risk
factors, and underlying mechanisms. The goal of this project is to test the hypothesis that SARS-CoV-2 promotes
cognitive decline in subjects who were previously normal via stimulating inflammatory pathways, with the
greatest risk being in older adults, females, and those from underrepresented groups. We propose to utilize
patients in our biorepository, who were hospitalized with SARS-CoV-2 infection, to achieve three Specific Aims:
(1) to determine the type and duration of neurocognitive dysfunction present; (2) to ascertain risk factors for
ongoing cognitive decline, including sex, age, race/ethnicity and comorbidities; and, (3) to verify that persistent
neuroinflammation underlies cognitive decline. To achieve these Aims, our team has established a well-curated,
highly diverse biorepository of more than 650 patients hospitalized with COVID-19. About 15% have succumbed
to COVID-related illnesses; however, 37% have continued to return for testing at 3-6 and 12-months post
hospitalization. Preliminary data demonstrates that 30% of subjects returning at one year show progressive
cognitive decline, which is associated with elevated markers of inflammation and neuronal stress. Here we
propose to follow these patients and perform detailed cognitive testing and assess biomarkers from their blood-
serum, spinal fluid, and imaging to explicate the type and time course of cognitive changes present, the risk
factors associated with cognitive dysfunction, and whether inflammation-induced neuronal distress underlies
progressive neurocognitive impairment. This proposal is innovative because we are evaluating the long-term
neurocognitive consequences of severe COVID-19 from a cohort that we have followed since the onset of the
pandemic, which has provided preliminary data supporting our Aims. Moreover, we have brought together
investigators with expertise in cognitive assessment and treatment, and basic and translational research, all in
the setting of a strong institutional infrastructure. Our work is significant because understanding the role of
persistent neuroinflammation in COVID-19-induced cognitive dysfunction will greatly enhance our ability to
rationally test immunosuppressants for this very debilitating disorder.

Public health relevance
PROJECT NARRATIVE Emerging data suggests that SARS-CoV-2 infections may lead to neurocognitive deficits, which can have a duration of at least a year post-infection, and are thereby very distressing. We have been following a cohort of 650 patients since discharge from our hospital, who were previously cognitively normal, and for whom 30% of returning subjects have progressive cognitive decline. Here we propose to follow and thoroughly investigate these subjects to answer these critical questions: (1) what are the characteristics of COVID-19 induced neurocognitive dysfunction, including its duration and anatomic localization; (2) what are its risk factors, including possibly sex, age, race/ethnicity and medical comorbidities; and, (3) what is the role of persistent inflammation in producing it, which is vital because a positive finding would lead immediately to trials of anti-inflammatory interventions for this devastating disorder.